Antibody display libraries for precision screening of antibody immune responses to SARS-CoV-2

Project Summary/Abstract
This project will develop a new technological approach for the comprehensive analysis of adaptive immune
responses, which holds the potential to catalyze new strategies to prevent and treat disease. Here we will
apply immune profiling techniques recently invented by the PI to investigate the mechanisms of Epstein-Barr
virus (EBV) adaptive immune control in clinical cohorts of infected patients. EBV is a highly prevalent pathogen
infecting >90% of the world’s population. Primary EBV infection often causes infectious mononucleosis (IM)
and long-term sequelae include numerous malignancies, lymphoproliferative disorders, and a strong
association with multiple sclerosis. No EBV vaccine is approved to date, and the molecular mechanisms of
immune protection from EBV-associated diseases are unclear. Unfortunately, prior technical barriers in high-
throughput immune profiling methods have prevented a comprehensive understanding of adaptive immune
protection against EBV diseases. A technological approach that identifies the critical features of EBV immune
protection will advance new solutions for vaccine and therapeutic development. Therefore, we developed an
experimental pipeline to enable rapid and cost-effective analysis of B- and T-cell responses to EBV that is
scalable to dozens of human patients per experiment. We hypothesize that a comprehensive B- and T-cell
analysis of carefully selected patient cohorts that either can or cannot suppress symptomatic infection will
reveal function-based correlates of EBV control. To test this hypothesis, we will apply quantitative immune
profiling technologies to analyze cryopreserved longitudinal samples from recently completed prospective
clinical studies of IM. Patient samples in our cohort span pre- and post-infection through convalescence and
encompass the full range of clinical IM severity scores (from 0, asymptomatic primary infection, to 6,
essentially bedridden with IM). Immune profile data will be used to establish adaptive immune correlates of IM
disease severity. In addition, we will analyze immune responses in apparently immunocompetent patients with
chronic active EBV (CAEBV) disease, or patients who do not adequately suppress EBV infection, to gain
insight regarding adaptive immune function and dysfunction in CAEBV. Finally, we will develop a new
computational toolkit to rapidly identify immune correlates from high-throughput datasets. Successful
completion of this project will constitute the first comprehensive functional B- and T-cell receptor analysis in a
human clinical cohort. Our efforts will provide a repertoire-scale, mechanistic understanding of adaptive
immunity to EBV and suggest new strategies for treatment and prevention of EBV-associated diseases. Our
long-term goal is to develop human immune profiling techniques as a platform approach to accelerate the
rational design of vaccines and therapeutics against pathogens of high public health importance, beginning
with EBV.

Public health relevance
Project Narrative This project will apply new high-throughput immune profiling technologies to elucidate the features of effective Epstein-Barr virus (EBV) immune control. EBV causes a range of human diseases including infectious mononucleosis and several forms of cancer; however, limited EBV treatment options are available and no approved preventive EBV vaccines exist. Our long-term objective is to apply enhanced understanding of adaptive immunity to accelerate the rational development of new vaccines and therapeutics.